Cerebellum-dependent learning over different time scales in an Alzheimer's Disease model

ABSTRACT OF PROPOSED SUPPLEMENT We will characterize cerebellum-dependent learning and memory in the 5XFAD mouse model of Alzheimer’s disease (Oakley et al., 2006), and compare impairments in these mice on different time scales: short-term (seconds, single trial), intermediate-term (tens of minutes, cumulative learning over a single training session) and long-term (days, consolidation). The Alzheimer’s mouse model can help achieve the parent grant’s scientific goal of dissecting the mechanistic relationship between different time scales of cerebellum-dependent learning. Moreover, there is evidence to suggest a role of the cerebellum in Alzheimer’s disease (Larner, 1997; Baloyannis et al., 2000; Ciavardelli et al., 2010; Mavroudis et al., 2010; Lomoio et al., 2012; Hoxha, et al. 2012; Baloyannis et al., 2013; Sepulveda-Falla et al., 2014; Kuwabara et al., 2014; Jacobs et al., 2017), but this is a highly understudied aspect of the disease compared to the role of the forebrain. The oculomotor system provides a sensitive and analytically tractable approach to understand broader learning and memory deficits in Alzheimer’s.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): RAYMOND, Jennifer L. PROJECT NARRATIVE Alzheimer's disease is characterized by a progressive loss of memory. This project will analyze the role of a brain region called the cerebellum in perturbations of short-, intermediate- and long-term learning and memory in a mouse model of Alzheimer's disease. OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page